Linking fat metabolism to hepatic fibrosis

Project Summary

Non-­alcoholic fatty liver disease (NAFLD), the most common of liver pathologies, is one of the most
profound health disparities. The molecular pathway(s) associated with the pathogenesis of NAFLD and its
subsequent progression to nonalcoholic steatohepatitis (NASH) remains elusive. We have previously shown that
Carcinoembryonic antigen-­related cell adhesion molecule 1 (CEACAM1) plays a critical role in insulin clearance
in the liver and links hyperinsulinemia to NAFLD/NASH. Preliminary data identify that Cell death-­Inducing
DFF45-­like Effector (Cidec;; also termed Fsp27), a lipid droplet associated protein that regulates lipolysis in the
adipose tissue, regulates liver metabolic function and fibrosis via hepatic CEACAM1. Most interestingly, we found
that FSP27–/– mice exhibited lower hepatic CEACAM1 levels on regular and HF diets, and subsequently,
impaired insulin clearance and hyperinsulinemia that could in turn, mediate hepatic insulin resistance. In addition
to hyperinsulinemia-­driven hepatic steatosis, Fsp27–/– mice also exhibited elevated plasma Endothelin 1 and
spontaneous hepatic bridging-­fibrosis, comparable to the phenotype of Ceacam1 knockout mice. To study the
gain-­of-­function we have developed an innovative adipose-­specific transgenic mouse model expressing human-­
FSP27. Our preliminary data show that this mouse model exhibits normal insulin and glucose tolerance in
response to HF intake in parallel to a remarkable ~5-­fold induction of hepatic CEACAM1 protein levels. Since
lipolysis-­derived fatty acids from white adipose tissue (WAT) reduces hepatic CEACAM1 expression and forced
liver-­specific overexpression of CEACAM1 or its adenoviral-­mediated delivery protects against HF diet-­induced
insulin resistance and steatohepatitis, and fibrosis in WAT and liver, we hypothesize that reduction of FSP27 in
adipocytes causes FFA release and redistribution to the liver to reduce hepatic CEACAM1 levels and
subsequently, cause hepatocyte injury and hepatic fibrosis. We postulate the underlying mechanisms to involve
activation of epidermal growth factor receptor by fatty acids and Endothelin 1, the expression of which is
upregulated by the MEK/ERK-­PPARg pathway. Aim 1 will investigate whether CEACAM1 in hepatocytes
regulates hepatic fibrosis in mice with adipocyte-­specific deletion of Fsp27 (paracrine regulation). Aim 2 will
examine the cell-­autonomous fibrogenic effect of FSP27 deletion in hepatic stellate cells. This approach is well-­
thought and well-­designed where novel mouse models (both knockout and transgenic) will be used to study the cross-­
talk between adipose tissue and liver which plays a critical role in the development of hepatic fibrosis via altering
FSP27. A strength of this proposal is an interdisciplinary collaboration between Drs. S. Najjar (fatty liver disease
and lipid metabolism) and V. Puri (adipose biology and lipid metabolism). As is clear from the strong preliminary data,
these scientists have productively collaborated on a proposal that will delineate the novel pathways in the
pathogenesis of NAFLD/NASH that might lead to novel treatments against this remarkable health problem.

Public health relevance
Narrative Nonalcoholic fatty liver disease (NAFLD) is the fastest growing cause of liver dysfunction with more than 80 million Americans (30-40%) being affected, and nearly 10 million being diagnosed with Non-alcoholic steatohepatitis (NASH). Its progressive form [nonalcoholic steatohepatitis (NASH)] is associated with hepatic fibrosis that can develop into cirrhosis. The proposed studies will identify genes associated with a cross-talk between adipose tissue and liver that plays a critical role in the pathogenesis and pathophysiology of NAFLD/NASH. The ultimate goal of these studies is to identify novel pathway(s) in the pathogenesis of fibrosis to develop appropriate therapeutic targets.